A culturally centered CBT protocol for suicidal ideation and suicide attempts among Latinx youth

Project Summary
The overall goal of this research program is to provide effective culturally relevant care to Latin families, and
address the NIMHD mission of reducing disparities in underserved and minority populations. Evidence-based
and culturally centered treatments for Latinx teens (Latinx = gender inclusive term) with suicidal ideation and
attempts (SIA) and their families are quite limited. Emerging evidence indicate that Cognitive behavioral
therapy (CBT) is a promising treatment approach in reducing suicidal ideation and attempts in Non-Latinx
White adolescents. However, culturally adapted treatments have been shown to benefit Latin families more
that non-culturally adapted treatments. This study is innovative in its use of a culturally centered CBT treatment
protocol (Socio-Cognitive Behavioral Therapy for Suicidal Behavior-SCBT-SB) to address the specific needs of
Latinx teens and their families. The SCBT-SB addresses central issues in adolescent identity formation (e.g.
ethnicity, sexual orientation), family interactions and communication, and parenting skills. The SCBT-SB was
developed with Latinx youth with SIA in Puerto Rico and further modified for Latin families in the US. Feasibility
of this modified version of the SCBT-SB was tested in the US by conducting a pilot RCT (n=46) of SCBT vs
treatment-as-usual (TAU) with positive results. It was found that SCBT-SB was feasible to implement in a
community mental health center with frontline therapists, acceptable to families, and showed reductions in
suicidal ideation and depressive symptoms. The scientific premise of the proposed study is that immigration
and acculturation (the process of assimilation to the host culture) and enculturation (maintaining cultural values
and costumes) experiences have an impact on SIA in Latinx teens; and that personalization of an evidence-
based treatment, according to cultural and immigration experiences, will result in better treatment outcomes
than TAU. This application proposes a hybrid efficacy/effectiveness trial with 160 suicidal Latinx teens
randomly assigned, following baseline assessment, to 2 treatment conditions, TAU and SCBT-SB. Follow-up
assessment will take place at 3, 6 and 12 months after baseline. All treatment will take place at a community
mental health clinic. The specific aims are: 1) To test the effect of the SCBT-SB versus TAU on suicidal
ideation in a clinical sample of adolescents under conditions of strong external validity, and 2) To test the effect
of the SCBT-SB versus TAU on depressive symptoms, given its high correlation with SIA. Exploratory aims
are: 3) To examine the effect of SCBT-SB versus TAU on suicide attempts, and 4) To examine potential
mediators (family environment) of treatment outcome. Successful completion of this study will positively impact
treatment of Latinx immigrant adolescents at high risk of SIA in the US.

Public health relevance
Project Narrative The primary aim of the proposed research is to test the effect of a culturally centered treatment protocol, the Socio-cognitive behavioral therapy (SCBT), versus Treatment as Usual on suicidal thoughts and attempts, and depressive symptoms, in a clinical sample of Latinx adolescents. The study is trying to determine, if we take into account perspectives of Latin immigrant families and minority youth, whether better outcomes can be found for this high risk group.